Center for Care Delivery and Outcomes Research (CCDOR)

The mission of the Center for Care Delivery and Outcomes Research (CCDOR) is to develop and evaluate
interventions and implementation strategies that improve health care delivery, Veteran engagement in
health care, and Veterans' health and functioning in their communities. CCDOR's vision is to elevate the
quality, consistency and equity of health care and outcomes for all Veterans through innovative health services
and implementation research. Building on 20 years of success, this application proposes the renewal of
CCDOR as a VA HSR&D Center of Innovation (COIN) at the Minneapolis VA Health Care System (MVAHCS).
The name of the Center has been modified to reflect the Center's strategic goals while preserving the CCDOR
acronym and identity recognition. Over the next 5 years, CCDOR's strategic plan focuses on 2 high priority
areas in which CCDOR's expertise and partnerships are exceptionally strong and where CCDOR is uniquely
positioned to make substantial and meaningful contributions to improving Veteran health and health care: (1)
Trauma Recovery, and (2) Chronic Pain and Opioid Harms Reduction. These priority areas are of critical
importance to Veterans and their families and are aligned with the VA priorities to enhance foundational
services, improve timeliness, and suicide prevention, as well as the Federal Pain Research Strategy.
CCDOR's strategic goals are:
1. Conduct research to improve health care, health care experience and outcomes among Veterans with
posttraumatic stress disorder (PTSD) and other trauma-related disorders. (Priority 1)
2. Conduct research to reduce opioid-related harms and improve health and functional outcomes for Veterans
with chronic pain. (Priority 2)
3. Support and conduct impactful and innovative health services research to discover and support delivery of
evidence-based practices on cancer prevention and control, healthy aging, and other important topics
outside CCDOR's 2 priority areas. (Additional Research)
4. Train health services researchers to conduct high impact, partner-oriented and implementation-focused
research and to become leaders in VA and national health care. (Mentoring and Training)
CCDOR is a vibrant health services research center of 26 core investigators leading research in Trauma
Recovery (Priority 1) and Chronic Pain and Opioid Harms Reduction (Priority 2), as well as conducing and
promoting research in additional areas. CCDOR's research is enabled by a management structure that
includes experienced and dedicated leaders and six Cores to facilitate Center functioning, training and
research. The CCDOR Evidence Synthesis and Implementation Cores are known nationally for their
methodological expertise and contributions to Veteran health care. CCDOR's Statistics and Data Management
Core not only enables CCDOR research but develops new methods and serves as a resource for operational
partners, informatics groups and researchers across VHA. The Veterans Engagement Core has expertise in
community engagement and Community Based Participatory Research and is using both Veteran Engagement
Studios and Veteran Advisory Panels to engage Veterans in CCDOR research. CCDOR has deep and strong
partnerships with VA Program Offices, including the Office of Mental Health and Suicide Prevention, the
National Center for PTSD, and National Pain Management. These partnerships help to ensure the value and
impact of Center research. Therefore, CCDOR is well-equipped to achieve its strategic goals, undertake the
projects described in this proposal and thereby improve care delivery, Veteran engagement in health care, and
Veterans' health and functioning in their communities.

Public health relevance
The mission of the Center for Care Delivery and Outcomes Research (CCDOR) is to develop and evaluate interventions and implementation strategies that improve health care delivery, Veteran engagement in health care, and Veterans' health and functioning in their communities. CCDOR's vision is to elevate the quality, consistency and equity of health care and outcomes for all Veterans through innovative health services and implementation research. CCDOR is a vibrant health services research center of 26 core investigators leading research in Trauma Recovery (Priority 1) and Chronic Pain and Opioid Harms Reduction (Priority 2), as well as conducting and promoting research in additional areas including cancer prevention and control, health aging, and other timely topics. CCDOR has deep and strong partnerships with VA Program Offices, including the Office of Mental Health and Suicide Prevention, the National Center for PTSD, and National Pain Management. These and other partnerships ensure the value and impact of Center research.